Cancer Center Administration

PROJECT SUMMARY/ABSTRACT (ADMINISTRATION)
The University of Michigan Comprehensive Cancer Center (UMCCC) Administration provides fundamental
resources and support for the Center to achieve its mission to reduce cancer burden and improve cancer
outcomes through research, innovation, transdisciplinary collaboration, education, and outreach and
engagement. The vision of the UMCCC is that through its focus on team science and research excellence, the
UMCCC will be a national leader in prevention, early diagnosis, optimal treatment, and survivorship care for
those at risk of or affected by cancer. This is accomplished through an efficient infrastructure that facilitates
timely and value-added assistance to UMCCC senior leaders and members to enhance collaborative research
within and across programs. The UMCCC Administration provides essential support to execute all governance,
planning, evaluation, space, and resource allocation functions for UMCCC. Administration adds value by
supporting seven research programs, 11 shared resources (SR) plus two developing SRs, and other key
components including education and training, clinical research, and community outreach and engagement.
UMCCC Administration oversees membership and research administration functions for 287 members across
50 departments and eight schools and colleges at the University of Michigan (U-M), with $101.4M in grants and
contracts and 4,401 publications in the project period. Administration advances the naturally interactive and
collaborative cross-disciplinary research environment and facilitates high-impact laboratory, clinical, and
population science discoveries. Led by Julie Brabbs, MBA, Associate Director (AD) for Administration and Chief
Administrative Officer, UMCCC Administration provides a reliable and strong foundation for the Center.